Zero Cryogen Boiloff Technology Magnet: A Regional Animal MRI Resource

ABSTRACT
This proposal requests support for a new animal MRI scanner magnet and gradients to replace the original
equipment that was destroyed in a recent untimely and unexpected magnet quench. After replacing the
magnet and gradients, the Animal MRI Core will again have a state-of-the-art system that supports research
from NIH-funded investigators representing four IDeA State institutions in the Midwest: University of Kansas
Medical Center, University of Kansas-Lawrence, Kansas State University, and Pittsburg State University. The
upgraded system will also support the research initiatives of seven NIH-funded centers: University of Kansas
Alzheimer’s Disease Center, University of Kansas Cancer Center, Kansas Intellectual & Developmental
Disabilities Research Center, University of Kansas Polycystic Kidney Disease Research & Translation Core
Center, Frontiers: University of Kansas Clinical and Translational Science Institute, and two CoBRE Centers
(Kansas State University Cognitive and Neurobiological Approaches to Plasticity Center and Kansas Center for
Metabolism and Obesity Research.
Our user group includes >20 NIH-funded investigators who have adopted MRI methodology to answer
complex biomedical questions in neurological, renal, pulmonary, and hepatic disease and through studies in
neurodegeneration, metabolism, obesity, pain, and developmental biology. With this scanner, these
investigators will have access to high-performance electronics that will provide many new acquisition
sequences for data acquisition and an intuitive graphical user interface based on clinical MRI scanner designs
which is more user-friendly to operators, thus opening access to a wider user group including graduate
students and post-doctoral fellows since their training period will be dramatically shorter. Accordingly, we
anticipate reduced imaging costs to investigators funds.
This system will be installed in the University of Kansas Medical Center Hoglund Biomedical Imaging Center. It
will be supported by strong institutional commitments to operating costs and an outstanding team of imaging
scientists who will collaborate with our Major and Minor Users on study design, imaging protocol development,
analysis of data and interpretation of results. We expect this system to quickly and dramatically increase in
research activity at the University of Kansas Medical Center as well as in the nearby region.

Public health relevance
Narrative Following the replacement of the failed magnet, we will have a fully functional animal MRI scanner that will provide state-of-the-art pre-clinical imaging for biomedical scientists from Kansas City and the surrounding region who use animal models of normal function and disease to develop new cures. Once commissioned, our investigators will continue a considerable body of NIH-funded work. This scanner will provide a user-friendly interface for programming and an extensive library of well-established acquisition protocols for scientists and an outstanding training environment for graduate students, post-doctoral fellows, and faculty scientists.